Short Term Training for Students in the Health Professions

Continued support is requested for a short-term ten-week research training initiative at Cornell University.
The program targets predoctoral veterinary students who aspire to careers in biomedical discovery or public
health. Trainees may have some or no prior research experience. Seven positions are requested in each of
the next five years. The program's objectives are: (i) To promote the commitment of veterinary student
trainees to a career in biomedical research; (ii) to nurture trainee interest in biomedical research as a career
through experiential learning, independent research, and research-related activities; (iii) to promote high
ethical standards, and the development of the creativity, leadership and teamwork skills necessary to
succeed in biomedical research; (iv) to empower students to make informed decisions regarding graduate
training and their careers by providing vocational counseling; and (v) to create a professional network that
will benefit the students beyond the completion of their formal training and veterinary education. The desired
outcome of the program is for the alumni of the program to seek advanced scientific training following
completion of their professional degree that will allow them to fulfill the nations need for veterinary scientists.
Training would be provided in outstanding modern facilities at the College of Veterinary Medicine and other
laboratories throughout the Cornell Ithaca Campus. The participating faculty trainers are nationally
competitive scientists and many have served as mentors for program scholars in the past. Several of the
participating faculty also serve as module facilitators and counselors. The scientific disciplines
encompassed by the program are broadly based and include virology, bacteriology, immunology,
parasitology, epidemiology, cancer biology, signal transduction mechanisms, biomedical engineering, and
others.
The Cornell program has been successful in identifying outstanding participants including subsequent
Rhodes and Fulbright scholars, and many individuals who graduated from veterinary college with the
University Medal or its equivalent. More than 200 alumni have earned the PhD degree or are presently in
training while many others have been awarded other advanced degrees in science or public health. An
enduring network of program participants, counselors and consultants is a unique legacy of the program. As
mentors, they are committed to assisting one another and more junior colleagues who are still in training.
Mechanisms have been established to validate elements of the program, and to identify problems
connected with the professional advancement of veterinary graduates who aspire to careers envisioned by
the program. An outcome analysis of alumni who participated in the program between 1990-2006 revealed
that 45% of those individuals have pursued science-based careers.

Public health relevance
NARRATIVE The proposed short-term research training program will encourage veterinary students to pursue careers in biomedical science and public health following completion of their veterinary degree by combining an intensive summer research experience with vocational counseling and student-directed workshops. This is relevant to public health as there is a recognized national shortage of such suitably trained veterinarians who play important roles in the recognition and control of emerging diseases and food safety.